Proteinase Inhibitors and Crystallin Fragments in Cataract

Cataracts are principally a disease of aggregation and subsequent precipitation of specific lens structural proteins (crystallins), Cataracts may be induced by genetic mutations, or may be associated with aging. In the course of cataract development, the aggregated and cross-linked crystallin multimers become so large that they finally become water insoluble and cause lens opacity. This proposal has the overall goal to determine the molecular mechanisms of congenital nuclear cataract development and of age-related cortical cataract development. We have generated two mouse models, a conditional βA3/A1 knockout (βA3cKO) mouse model and an αA-N101D transgenic mouse model. Characterization of the βA3cKO mice by the PI has established their validity as a model of congenital nuclear cataract development, and will serve as a model system to better understand the molecular mechanism of βA3-mutation-induced pediatric cataracts. Characterization of the αAN101D mice by the PI has established its validity as a model of deamidation-induced age- related cortical cataract development. Based on our results and results of others, our central hypothesis is that: (A) Congenital cataract in the βA3-cKO mouse model is caused by a dysfunctional degradation process (autophagy) due to the absence of βA3 as a lysosomal resident protein, accelerated calpain-induced proteolysis of lens proteins, and disruption of protein-protein interactions; and (B) The age-related cortical cataract in the αAN101D mouse model is caused by intracellular ionic imbalance due to increased membrane binding of αAN101D, leading to calpain activation, changes in cellular junctions and actin filaments due to altered RhoA, Cdc42, and Rac activities, and the loss of protein-protein interactions. We hypothesize that in cataractogenic mechanisms of both models, the aggregation of truncated crystallin fragments produced by calpain plays a major role. We plan to test our central hypothesis in these mouse models in three aims: (A) Aim1: What is the role of βA3 crystallin in autophagy blockade (in βA3KO mice), and what is the role of calpain activation and protein-protein interactions in the cataractogenic mechanisms of both βA3cKO and αAN101D mice? (B) Aim 2: What is the molecular mechanism of cataract development in transgenic αAN101D mice? (C) Aim 3: What are roles of crystallin fragments generated by proteolysis of lens proteins by calpain in cataract development of βA3cKO and αAN101D mouse models? We expect that the findings will provide insights to guide us toward improved therapeutic intervention to delay or cure congenital pediatric and age-related cataracts.

Public health relevance
The proposal has the overall goal to determine the molecular mechanisms of congenital nuclear cataract development in a conditional βA3/A1 knockout mouse model, and in an age-related cortical cataract development in αAN101D transgenic mouse model. The proposed studies will provide answers to the central questions about roles of βA3/A1 crystallin and deamidated αAN101D in the development of congenital nuclear cataract and age-related cortical cataract, respectively. The findings would guide us to therapeutically delay or cure above two types of human cataracts.